WashU-WRHR; Gateway to Improving Women's Reproductive Health

PROJECT SUMMARY/ABSTRACT
Our goal in this new WRHR is to leverage the significant resources, mentorship, and track record of successful
physician-scientists within WashU and the Department of OB/GYN to train and promote the development of
future leaders in interdisciplinary research in women's reproductive health. The WashU WRHR program will have
three core content themes – 1) Pregnancy and pregnancy complications, 2) Gynecologic cancer, and 3) Benign
gynecology and reproductive health – and four methodologic tracks: 1) Clinical trials and epidemiology, 2)
Implementation science, 3) Basic and translational science, and 4) Engineering and data analytics. This program,
designed with input from successful OB/GYN physician-scientists who launched their careers at WashU, will
allow the WRHR Scholars to immerse themselves in reproductive sciences and use the skills and knowledge of
diverse scientific disciplines to conduct rigorous, high-impact research aimed at improving women's reproductive
health. We will accomplish our goal by pursuing the following four objectives: 1) Provide robust interdisciplinary
research experiences in women’s reproductive health. Each Scholar, with the guidance of Mentors, the Program
Director (PD), and the Research Director (RD), will design a research project centered in one of our three core
content themes. The Scholars' research projects will be the foundation for subsequent grant proposals as
independent investigators directing research teams. 2) Provide effective mentoring to promote Scholars’
retention and productivity. Each Scholar will have an interdisciplinary mentor team that includes a primary mentor
and at least two secondary extra-disciplinary and external mentors. The mentors, PD, and RD will guide the
Scholars to understand research and the research landscape, develop critical assessment skills, ask creative
questions, and identify and overcome challenges. The PD and RD will regularly monitor each Scholar’s progress,
provide feedback to overcome obstacles to success, and work to retain them in the pursuit of women’s
reproductive health research. 3) Provide formal didactic training and professional development opportunities.
We will help each Scholar choose the most relevant discipline-specific courses, seminars, and symposia within
one of our four methodologic tracks. Additionally, all Scholars will participate in core professional development
programs and peer networking to master essential research execution, management, and leadership skills. And
4) Rigorously and comprehensively evaluate and improve our program. The Advisory Committee will annually
use milestone tracking to evaluate each Scholar and the program as a whole. Additionally, WashU-WRHR
leaders will participate in the WashU Council of NIH-funded Training programs to learn and share best practices,
exchange ideas, and work to continually enhance our program.

Public health relevance
PROJECT NARRATIVE/PUBLIC HEALTH RELEVANCE To solve complex problems in women's reproductive health, we need for more obstetricians and gynecologists to conduct research. This training program will provide didactic courses, one-on-one mentorship, and career development for OB/GYNs interested in pursuing research in women's reproductive health for their career.